Streamlined and comprehensive brain-derived tear exosome profiling by microfluidic arrayed nanoplasmonic sensors and actuators

PROJECT SUMMARY
Despite keen interests in early diagnosis of Alzheimer’s disease, which faces a multitude of
underlying nuanced and mixed pathologies, the progress has been hampered by insufficient
sensitivity and low specificity to the pathology. New molecular assays include cerebrospinal fluid
measurements and brain amyloid plaque imaging through positron emission tomography (PET).
However, these techniques face limitations as they either require lumbar punctures, have
insufficient sensitivity for early detection, or are too expensive for wider adoption. As a result,
there is an unmet need in timely and cost-effective AD diagnostics.
Detection of disease biomarkers in the blood, known as “liquid biopsy”, can in principle
improve the accuracy of measuring nearly invisible diseases. Although existing liquid biopsy
concerns primarily with blood circulating biomarkers, detecting them in other bodily fluids such as
tears would potentially be completely non-invasive. Exosomes are cell-excreted extracellular
vesicles that contain surface proteins and genetic materials (DNA and RNA) that reflect the
characteristics and make-up of the parental cells. Analyzing brain-derived exosomes (BDE) would
therefore provide direct insight into the state of the parental cells of neuronal and glial origins. For
Alzheimer’s disease diagnostics, in particular, recent pieces of evidence have shown that several
pathological surface proteins and cargo micro-RNAs are differentially expressed in BDE in AD.
Therefore, unlocking the wealth of information in circulating BDE can potentially cause a paradigm
shift. However, current limitations for profiling BDE are the following: (1) only blood has been
studied; (2) sophisticated protocols; (3) label-free sizing/counting lacks molecular specificity; (4)
providing highly averaged results with high background from normal exosomes, thus leading to
poor sensitivity. (5) provide “partial” information: either surface antigen or cargo DNA/RNA, but
not both. All of the above has hampered the development of further understanding of BDE
associated with AD and a potential tear test for AD diagnostics. In this Administrative Supplement,
we propose to extend the microfluidic arrayed nanoplasmonic sensor & actuator (MANSA)
platform in the original R01 to single BDE profiling in tears. The MANSA platform will enable: (1)
streamlined operation from capturing to profiling. (2) improved sensitivity by digital counting
via dynamic imaging. (3) improved specificity by profiling multiple surface proteins and cargo
microRNA associated with AD pathologies. A high-resolution, exosome array with multiplex
surface protein and cargo microRNA profiles will facilitate high dynamic range enumeration and
boost sensitivity in tear-based AD diagnostics and accentuate high-value AD biomarkers. The
proposed technology would lead to a cost-effective, point-of-care-friendly, translational
platform.

Public health relevance
PROJECT NARRATIVE Streamlined and comprehensive molecular profiling of brain-derived exosomes (BDE) in bodily fluids such as tears would provide a new avenue for unlocking the wealth of information reflective of the parental cells. Selective immunocapturing and concentrating of exosomes on a bio-chip examined at microscopic resolution are critical for accentuating the circulating BDE signal among a large background from the vast majority of other exosomes. We propose to develop a novel technological platform to provide radical advancement in the ability to count single exosomes and associate the surface protein and cargo genetic biomarkers with Alzheimer’s disease in tears, a goal aligned with NIH’s mission of developing new approaches critical for AD research and diagnostics.